Role of Prohibitin Nitrosylation in its Neuroprotective Functions

Project Summary/Abstract
The mitochondrial protein Prohibitin (PHB) is essential for life. Its importance to cellular activities
is attested by the fact that deletion of PHB is embryonic lethal in mice and that to date no
mutation has been found in the coding region of PHB in any neurological disease conditions,
indicating that PHB integrity is essential and that somatic mutation is detrimental. Our recent
work has demonstrated that PHB has remarkable neuroprotective potential against ischemic
brain injury with an underlying mitochondrial associated mechanism. Its expression is critical for
mitochondrial function in stress situations. However, how this important protein that are stable at
both mRNA and protein levels, is functionally regulated in neuroprotection, as well as how it is
dysregulated in other neurological conditions, remain surprisingly unknown. In exploring the
mechanisms of PHB regulation, we discovered that nitric oxide (NO) is required for PHB
expression mediated neuroprotection. Therefore, we investigated the interaction between NO
and PHB and found that NO modifies PHB post-translationally, through protein s-nitrosylation, a
novel regulatory mechanism similar to protein phosphorylation. In this application, we propose
to study the effects of PHB S-nitrosylation and the mechanisms underlying functional regulation
of PHB by NO. Our central hypothesis is that nitrosylation is critical for PHB’s
neuroprotective function and, consequently, disturbances of PHB nitrosylation are
detrimental and contribute to pathology. We will use a novel mutant knock-in mouse, in
which the sole cysteine residue of PHB protein is mutated so that PHB cannot be nitrosylated,
to analyze the mechanisms of NO regulation and the effects of loss of PHB nitrosylation on PHB
function, in the settings of brain ischemic injury in association with mitochondria structural
alterations. Three specific aims will systematically test the hypothesis. The results of the
proposed studies will reveal a previously unrecognized regulatory mechanism of PHB which we
believe is crucial to facilitate the design of potential therapies that could ultimately benefit
patients at risk of stroke and other neurological diseases.

Public health relevance
Project Narrative The proposed studies will investigate a novel aspect of prohibitin (PHB) in that the function of this important protein is dictated by the cellular environment. This form of functional regulation is directly related to its role in the ischemic neuronal injury and on mitochondrial functions. The findings will advance our understanding of the fundamental processes governing neuronal survival and death through regulation of mitochondrial functions, and have the potential of identifying mitochondria targeted treatment strategies for stroke and other neurological diseases linked to mitochondrial dysfunction.